Chromatin State Alterations in Fanconi Anemia Hematologic Disease and Bone Marrow Failure

PROJECT SUMMARY/ABSTRACT
Fanconi anemia (FA) is a genetic disease characterized by congenital abnormalities, hematologic disease and
bone marrow failure, increased cancer risk, and premature mortality. Therapeutic options for FA are extremely
limited and the overall life expectancy of FA patients is only 29 years. The molecular etiology of FA is poorly
understood and no rational therapeutic approaches based on the biochemistry of this disease have been
developed. Consequently, the prognosis for FA patients - and their families and loved ones - is poor. Progress
in this field will only be achieved by a greater understanding of the molecular basis of this disease,
underscoring the significance of our proposed studies.
FA is caused by mutations in any one of 23 genes. The FA proteins function to repair DNA damage and to
maintain chromosome stability. A key step in the activation of the FA pathway is the monoubiquitination of the
FANCD2 and FANCI proteins, which occurs upon exposure to DNA damaging agents. The monoubiquitination
of FANCD2 and FANCI promotes their assembly into discrete chromatin-associated foci. The mechanisms by
which FANCD2 and FANCI are targeted to, retained in, and function within chromatin are, however, largely
unknown. Importantly, FANCD2 and FANCI monoubiquitination is defective in >90% of FA patients and
integral to FA patient BMF and hematologic disease.
The overarching goal of our 3-year SHINE II R01 research proposal (parent award) is to elucidate the
molecular underpinnings of the connections between FA and chromatin plasticity. Directly related to this goal,
we propose that FANCD2 regulates the expression of select large transcriptionally active units under
conditions of replication stress. We further speculate that the cohort of FANCD2-regulated large genes will be
cell-type specific. The major goals of this Graduate Student Diversity Supplement are to directly test these
hypotheses. Our studies have the potential to open a new avenue of therapeutic intervention for FA.

Public health relevance
NARRATIVE Fanconi anemia (FA) is a genetic disease characterized by congenital abnormalities, hematologic disease and bone marrow failure, increased cancer risk, and premature mortality. Therapeutic options for FA are extremely limited. In this cost extension for a Graduate Student Diversity Supplement, PhD candidate Justin Blaize will continue to determine the role(s) of the FANCD2 and FANCA proteins in the transcriptional regulation of a subset of large genes. These studies have the potential to open a new avenue of therapeutic intervention for FA.